Investigator Development Core

ABSTRACT
The Investigator Development Core (IDC) will ensure that the NYCenter for Advancing Translational Research and Health (NYCenter), addresses the development of early-career investigators in basic biomedical, behavioral, and clinical research through a pilot project program, mentoring, and other professional development activities. The pilot project program will allow researchers to generate preliminary data for grant applications, mainly focusing on research that addresses health disparities. Additional IDC professional development opportunities to increase junior faculty and post-doctoral fellows' participation, advancement, and leadership capabilities will be linked to this core. The core goal is to enable our junior researchers to successfully apply for extramural funding and progress in their academic careers. The specific aims of the core are to:
1) Develop and administer a pilot project program within the NYCenter focused on the academic development of junior faculty and post-docs across the full spectrum of research focused on addressing health disparities.
2) Mentor the pilot project investigators for their career development, publications, and research outcomes derived from pilot project funds.
3) Implement and facilitate a grant submission timeline for extramural funding appropriate to the pilot investigator's career stage. The IDC is envisioned as a magnet and an engine - a magnet that attracts early-stage investigators into health disparities research and an engine that nurtures them toward success in NIH grant funding. Findings from the proposed pilot project health disparities research program will lead to new K, R, and equivalent extramural grants, the outcomes of which will contribute to healthier communities in NYC and across the nation.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.